Gene and Variant Curation Expert Panels for Hearing Loss

ABSTRACT
Hearing loss (HL) is the most common sensory disorder worldwide, with significant genetic, allelic, and
phenotypic heterogeneity. Due to its complexity, HL presents many challenges in diagnosis, management, and
treatment, with over 220 genes and 16,000 variants implicated in its nonsyndromic and common syndromic
forms. The Hearing Loss Clinical Domain Working Group (HL-CDWG) established within the Clinical Genome
Resource (ClinGen) has addressed these challenges through the curation of gene-disease relationships (GDRs)
and assessment of the pathogenicity of variants associated with HL to enhance the diagnostic accuracy and
clinical care of persons with HL. This work is particularly timely, given the rapidly increasing number of genes
identified for clinical testing and ongoing clinical trials for genetic HL. The HL-CDWG is an international,
multidisciplinary team of over 50 members from 40 institutions across six continents, specializing in the key areas
of expertise with representation of research, clinical practice, and diagnostic laboratories. This group consists of
HL experts - geneticists, basic research scientists, auditory biologists, otolaryngologists, audiologists, and
genetic counselors - along with gene curation framework experts and biocurators ensuring a comprehensive
approach to addressing genetic HL. The HL-CDWG is structured into the HL Gene Curation Expert Panel
(GCEP) and the HL Variant Curation Expert Panel (VCEP). These panels have collaborated to refine the
evidence supporting GDRs and variant classification. In this proposal, we will build upon and expand the activities
of the HL-CDWG. In Aim 1, we will thoroughly curate the evidence supporting GDRs and quantify their strength
using the ClinGen framework. In Aim 2, we will develop standardized, evidence-based gene-specific variant
classification guidelines specifically tailored to each gene's mutational signature and molecular mechanism. We
will prioritize genes targeted in gene therapy-based clinical trials and those with pleiotropic effects. This effort
enhances the precision of genetic testing and interventions, aligns with successful clinical trials for genetic HL,
and marks a pivotal step towards precision medicine. The work of the Hl-GCEP and VCEP will be disseminated
through publications, webinars, and workshops at meetings targeted at the clinical and research communities in
otolaryngology and the broader genetic community. This strategy ensures the effective implementation of an
evidence-based framework and practices to enhance patient care and improve health-related outcomes and
aligns perfectly with the 2023-2027 strategic plan of the National Institute on Deafness and Other Communication
Disorders.

Public health relevance
PROJECT NARRATIVE Hearing loss is the most common sensory disorder worldwide with significant genetic, allelic, and phenotypic complexities making its diagnosis challenging. We bring together a multidisciplinary, international group from 40 institutions across 23 countries to curate gene-disease relationships and refine variant classification frameworks for hearing loss. These efforts aim to enhance the accuracy and effectiveness of genetic testing and care of individuals with hearing loss.